Core-003

Programs and activities outlined in Translational Endeavors will rigorously prepare a translational workforce and provide pilot funding to seed the formation of new collaborative teams. Each of these programs utilize a framework based on the idea that translational research and workforce development are best accomplished in an environment in which approaches are defined by the questions being asked, and/or the problems being solved, rather than by discipline-specific curricula. Our collective institutional creativity and our unique culture of collaboration provide an ideal setting for a transdisciplinary approach, in which investigators from different disciplines work jointly to create new concepts, methodologies, and translational paradigms that move beyond individual disciplines to address a common problem. UMCCTS education and professional development programs provide training in key principles, practice, and tools of clinical translational research across the translational spectrum. With CTSA support, we will refine and extend innovations in our approach to workforce development, including new training programs for clinical research professionals and biomedical engineers, and collaborate with the CTSA Network to expand entrepreneurship programs and collective experiential learning. These efforts are complemented by a Pilot Translational and Clinical Studies Program, which has been an outstanding success and which is consistently ranked by investigators as one of the most valuable UMCCTS resources. Our pilot programs will continue to leverage CTSA funding with institutional and industry funding to support transdisciplinary projects across the translational spectrum.

Public health relevance
Programs and activities outlined in Translational Endeavors will rigorously prepare a translational workforce and provide pilot funding to seed the formation of new collaborative teams. Each of these programs utilize a framework based on the idea that translational research and workforce development are best accomplished in an environment in which approaches are defined by the questions being asked, and/or the problems being solved, rather than by discipline-specific curricula.